Administrative Core

PROJECT SUMMARY – Administrative/Program Enrichment Core
The overall goal of the Administrative/Program Enrichment Core (Admin Core) of the San Diego Nathan Shock
Center (SD-NCS) is to facilitate and promote research into the basic mechanisms of aging, with an emphasis
on revealing heterogeneities in the aging process. The Admin Core will serve as the central point of contact for
all SD-NCS activities, maintaining lines of communication between SD-NSC Cores, as well as between SD-
NSC and the External Advisory Panel, other Nathan Shock Centers (including the Nathan Shock Centers
Coordinating Center (NSC3)), the external research community, and other regional research Centers. The
Admin Core will serve three key functions. First, the Admin Core will oversee activities of the three Research
Resource Cores, namely the Human Cell Models of Aging Core, the Heterogeneity of Aging Core, and the
Integrative Models of Aging Core, to ensure that high quality and efficient services are provided to investigators
performing aging research. This will include both operational and financial oversight. The Admin Core will help
to coordinate the flow of data and resources between Cores (workflow optimization), as well as the
dissemination of data and resources to research labs. The Admin Core will perform regular quality control
assessments, monitor the uptake of Core services by the research community, and balance demand for Core
services with workflow capacity. Finally, the Admin Core will coordinate efforts of an External Advisory Panel
and implement panel recommendations to improve Core services. Second, the Admin Core will facilitate efforts
of the Research Development Core to launch new aging research projects and to promote faculty development
and training. The Admin Core will coordinate efforts to establish and maintain a robust career development
program for aging investigators, with an emphasis on junior investigators and established investigators
entering the aging research field. The Admin Core will help run a pilot grant program, run logistics for training
workshops, and facilitate a mentorship program. Effectiveness of these programs will be monitored and
evaluated by the Admin Core, and adjustments made to these activities based on input from the Executive
Committee and External Advisory Panel. Third, the Admin Core will organize and oversee outreach activities of
the SD-NSC. This will include establishing and maintaining a website to advertise SD-NSC Core services and
NSC accomplishment; interfacing extensively with NSC3, other NSCs, the three SD-NSC participating
Institutions, and other regional research Centers to foster collaborations; working with the Salk
Communications Office to publicize SD-NSC accomplishments; and organizing lectures, symposia, podcasts,
and community events to widely broadcast the importance of aging research. Finally, to accomplish these
tasks, the Admin Core will provide project management services to ensure the three Phases of SD-NSC set-
up, launch, and operation are completed on time and that deliverables are achieved. This will include collection
of quantifiable metrics relevant to all SD-NSC activities to measure success in collaboration with NSC3.